TREATMENT OF OBESITY WITH BROMOCRIPTINE

This is a prospective, placebo controlled, multicenter trial to determine if "normalizing" the prolactin secretory pattern in obese individuals will lead to a decrease in lean body mass.